EvolvingSTEM: a classroom research curriculum in microbiology that helps students see themselves as scientists

The EvolvingSTEM laboratory uses a guided research experience to increase student confidence
in their ability to act and think as scientists. Students take part in an authentic bacterial evolution
experiment that can be conducted almost anywhere with minimal equipment. High school students learn microbiology, genetics, and biotechnology through the organizing principle of evolution, seeing obvious, heritable changes in bacterial colonies as they adapt to produce biofilm in just a few days. The experiment is biomedically relevant in simulating evolution during infections because related pathogenic bacteria adapt during chronic infections by identical mutations. An accompanying bioinformatics module provides students experience in data science when they identify mutations from whole-genome sequencing data generated from prior student research. Students learn to work through productive uncertainty, to engage with the material in ways that traditional life science education cannot, and to build their capacity for critical reasoning. Investigations such as ours allow students from all backgrounds to form a sense of agency to see themselves as scientists and motivate their interest in related careers.
This proposal will test the overarching hypothesis that our program can improve topical learning
and occupational interests in STEM for students throughout Western Pennsylvania.
Our goals are to (1) improve high school student attitudes towards learning essential life science
topics, such as evolution, microbiology, and genetics, (2) improve understanding of how microbes evolve and influence our lives, (3) provide practical skill development in laboratory methods and data science, and (4) motivate their interest in pursuing careers in STEM, partly by helping them to identify as researchers. We will assess program impacts on subject learning and STEM attraction and will test the influence of near-peer mentors and an extended inquiry module on these outcomes (Aim 1). We will also measure the persistence of changes in attitudes towards STEM and students’ own identities as researchers. In addition, we will reinforce the accessibility of our curriculum to students of varied interests and experiences and deepen its relevance to medicine, public health, and data science (Aim 2). We will also build a cloud-based visual workflow to teach students principles of data science when analyzing genomic data produced by students’ experiments.

Public health relevance
The EvolvingSTEM program will use a research-education partnership to educate high school introductory biology students about evolutionary biology, microbiology, and their impact on human health using authentic experimentation and 21st century bioinformatic skills. Our program increases understanding of these topics and their connection to biomedical advances and public health. Our program will improve design and implementation of research experiences that involve high school students in research methods and concepts that are rarely available in conventional classroom activities, and will determine which interventions (e.g., near-peer mentorship, student-driven inquiry) lead to sustained engagement in STEM and pursuit of STEM-related careers.